Rates of brain acetylome remodeling in a mouse model of diabetes and tauopathy

Alzheimer's disease (AD) is one of the top ten causes of death in the United States, and there is
no cure. AD is characterized by tauopathy, the accumulation of hyperphosphorylated microtubule-
associated protein tau (MAPT, tau), and is linked to metabolic dysregulation. Type 2 diabetes
mellitus (T2DM) is a risk factor for late-onset AD, but the mechanistic link between the two is
unclear.
Post-translational protein lysine N(epsilon) acetylation by the central metabolite acetyl-CoA has
been identified as an essential regulatory mechanism in intermediary metabolism, epigenetics,
and protein stability. T2DM is characterized by altered substrate metabolism, which impacts
acetylation and deacetylation co-factors NAD+ and acetyl-CoA. Dysregulated histone and tau
acetylation have been linked with age-dependent memory impairment. In vitro studies suggest
that acetylation contributes to tau aggregation. The in vivo impact of site-specific acetylation on
brain protein, including tau turnover, is unknown.
To investigate this, we developed a 2H2O (stable isotope)-based mass spectrometry method to
quantify protein turnover and assess the effect of post-translational modifications (PTMs) on
protein stability in vivo. The study aims to evaluate the role of acetylation on brain proteome
dynamics in the htau mouse model of AD. The first aim quantifies proteome and acetylome
dynamics in the hippocampus and frontal cortex of diet-induced diabetic and non-diabetic AD
mice to determine the effect of T2DM-related dysregulated acetylation on brain protein stability in
vivo. The second aim assesses the role of T2DM on the acetylation turnover of brain proteins in
vivo. The research team will also determine how T2DM-related altered acetylation contributes to
tauopathy and cognitive decline in AD. These experiments will establish the feasibility of the
acetylome dynamics method and motivate the development of new AD therapies.

Public health relevance
Alzheimer’s disease (AD) is a prevalent form of dementia and one of the top ten causes of death in the US, yet no reliable therapies currently available. Type 2 diabetes mellitus (T2DM) is a risk factor for late-onset AD and is associated with altered acetylation of proteins involved in tauopathy, pathological accumulation of phosphorylated tau in AD. The proposed research aims to investigate the rates of acetylation, deacetylation, and stability of acetylated proteins, including tau, to better understand the mechanism of tauopathy in a humanized htau mouse model of AD.